Lipid signaling in Hippo pathway regulation

PROJECT SUMMARY
Over the past decades, the Hippo pathway has been recognized as a crucial signaling pathway that
controls organ and tissue size, by restricting cell proliferation and anti-­apoptosis. The Hippo pathway can be
regulated by a wide range of extracellular signaling, including perceived physical signals from cell
microenvironment (i.e. contact inhibition, cell polarity, cytoskeleton-­based mechanical cues), growth
factors/mitogenic hormones (i.e. LPA and S1P regulated GPCR signaling), and recently discovered metabolic
status (i.e. energy stress, hypoxia). Mechanistically, almost all these stimuli or conditions operate YAP activity
through LATS1/2 kinases. The major knowledge gap for current Hippo signaling comes from the
uncharacterized mechanism for LATS1/2 regulation. The overall objective of this proposal is to elucidate the
regulatory mechanism for LATS1/2 kinases in response to Hippo upstream signaling events.
The detailed regulatory mechanism for LATS1/2 kinases could be complex, since multiple upstream
kinases including MST1/2, MAP4Ks, TAO1-­3, are able to phosphorylate LATS1/2 and required for LATS1/2
activation. It is still unclear how these identified kinases are coordinated to transduce upstream signaling to
activate LATS1/2. Besides, small Rho GTPase together with F-­actin can sense upstream signaling to modulate
LATS1/2 activities, however, the underlying mechanism is also largely unknown. Therefore, over the past few
years, we have conducted a proteomic analysis of the major components and regulators in the Hippo pathway
to pursue the answer to these questions. Unfortunately, our findings and findings from other labs failed
identifying such a putative “mediator” to fill the current knowledge gap in the Hippo pathway. Unexpectedly and
excitingly, our preliminary studies have discovered phosphatidic acid (PA) and it related lipid signaling as a
critical signaling axis involved in the Hippo pathway regulation. PA could function as a second messenger to
directly associate with LATS1/2 kinases and regulate LATS1/2 activities. Remarkably, PA’s level as well as the
activity of PLD1, a key enzyme that catalyzes PA production, are both decreased in response to the Hippo-­
activating stimuli or conditions. On the basis of these observations, we hypothesized that PLD1-­PA axis could
play a crucial role in regulation of LATS1/2 activities. Specifically, we propose to 1) determine the role of PA in
YAP regulation, particularly focusing on the independent role of PA from LPA in YAP activation;; 2) elucidate
the mechanism by which PA activates YAP. We will dissect the role of PA in LATS1/2 suppression through its
association with LATS1/2 and NF2;; and 3) investigate the role of PLD1-­PA axis in LATS1/2 regulation in
response to Hippo upstream signaling. Collectively, our proposed study will reveal a crucial regulatory
mechanism to control LATS1/2 activation in response to the Hippo upstream signaling and conceptually
advance our understanding of the Hippo pathway by filling this knowledge gap.

Public health relevance
PROJECT NARRATIVE The Hippo pathway, which is conserved from Drosophila to mammals, has been recognized as a crucial signaling pathway governing cell proliferation and apoptosis, two key events involved in tissue homeostasis and organ size control. Although several upstream regulators, conserved kinase cascade, key downstream effectors and nuclear transcriptional factors have all been identified, the detailed regulatory mechanisms for the Hippo pathway remain to be elucidated. My proposed research will focus on a new lipid signaling branch in regulation of the Hippo pathway, which will provide us an opportunity to uncover additional components/regulators for this putative pathway.